The impact of senescence on immune memory

PROJECT SUMMARY
It is well known that age-related changes in the immune system contribute to declines in the ability to mount a
highly protective response following either infection or vaccination. While vaccination does improve the outcome
of influenza (flu) infection in older adults, it is still foremost among all infectious diseases causing death and
disability in this population. Importantly, aging impacts almost every aspect of the adaptive immune response to
influenza including generation of virus-specific CD4 and CD8 T cell effectors, high affinity antibody production
and generation of protective immune memory. One of the most prominent features of aging is the accumulation
of senescent cells (SC) in various tissues and in this project, we will explore the role of SC in shaping the
generation of protective immune memory following influenza infection.
Cellular senescence is characterized by irreversible growth arrest that occurs when cells experience a stressor.
Senescence has two main roles in an adult: one is to suppress cells that have incurred DNA or other damage to
prevent them from transitioning into cancer, the other is to aid in wound healing. While SC are efficiently cleared
by the immune system in young individuals, this is not the case as we get older. With chronological aging, the
number of senescent cells increases, resulting in many age-related pathologies and diseases. In addition, factors
secreted by senescent cells (the Senescence Associated Secretory Phenotype, SASP) can also have a direct
impact on surrounding cells driving dysfunction and misdirected differentiation.
In this project, we will use two experimental models to examine the impact of SC on the immune responses
generated following an influenza infection, with a focus on generation of protective immune memory. The first is
the p16-Trimodality Reporter (p16-3MR) transgenic mouse model developed in the Campisi lab and the second
is the treatment of aged C57BL/6 mice with senolytics. Importantly, our preliminary studies have shown that
eliminating SC in aged mice prior to flu infection has a negative impact on the generation of protective immune
memory. The goal of this proposal is to further explore how deleting SC in aged mice impacts immunity and the
transition from the effector phase to the generation of durable protective memory. This proposal has high
translational significance as clinical trials for the senolytics for infectious diseases, such as COVID-19, are
already underway and it is important to determine if this treatment could impair protective memory formation and
leave at-risk older adults at risk for severe reinfection.

Public health relevance
PROJECT NARRATIVE It is well known that age-related changes in the immune system contribute to declines in the ability to mount a highly protective response following either infection or vaccination. Our preliminary studies have shown that eliminating senescent cells in aged mice prior to flu infection has a negative impact on the generation of durable protective immune memory. This project will use 2 experimental models to examine the impact of senescence on the adaptive immune response to influenza infection including phenotypic and transcriptomic analyses of both effector and memory stages.